PDGFbeta Receptor Activation Promotes Atheroprotective Changes in SMC Phenotype

Atherosclerosis is a progressive disease that is a leading cause of death in the Western world. Remarkably, despite decades of research, there remain major ambiguities regarding the role of smooth muscle cells (SMC) in lesion pathogenesis, as well as mechanisms that control plaque stability and the probability of plaque rupture with possible myocardial infarction (MI) or stroke. The general dogma is that SMC are primarily involved in late not early stage lesions, and that their primary role is atheroprotective by contributing to formation of a fibrous cap. However, recent Nature Medicine studies by our lab involving simultaneous SMC-specific lineage tracing and knockout (KO) of the stem cell pluripotency genes, Oct4 or Klf4 provided compelling evidence that SMC play a much greater role in lesion pathogenesis than has been generally appreciated. Key findings include our showing that: 1) >80% of SMC-derived cells within advanced lesions of ApoE-/- mice lack detectable expression of typical SMC markers; 2) 30-40% of SMC-derived cells within both advanced mouse and human lesions lack detectable SMC markers and have activated markers of M?s; and 3) SMC can have major beneficial or detrimental effects on lesion pathogenesis depending on the nature of their phenotypic transitions. Thus, there is a critical need to identify factors and mechanisms that promote beneficial changes in SMC phenotype. Studies in this proposal will test the overall hypothesis that PDGFβR-dependent changes in SMC phenotype are atheroprotective and that augmentation of the PDGFβR signaling pathway should be one of the primary therapeutic targets for treating advanced atherosclerosis. This hypothesis will be tested in two specific aims. Aim 1 will test the hypothesis that PDGFβR- dependent transitions in SMC phenotypic play a critical role in the development and progression of atherosclerosis. Aim 1a will extend our initial studies showing that SMC specific conditional PDGFβR KO at 6-8 weeks of age followed by 18 weeks of Western diet (WD) resulted in BCA lesions that were larger but virtually lacking SMC to include rigorous analysis of indices of plaque stability and mechanisms for reductions in SMC number within lesions. Aim 1b will test the hypothesis that SMC-specific conditional KO of PDGFβR results in detrimental transitions in SMC phenotype including increased numbers of SMC-derived Lgals3+ foam cells (SMC-FC) and reduced numbers of SMC derived myofibroblasts (SMC-MF) within the fibrous cap. Aim 2 will test the hypothesis that PDGFβR-signaling pathways confer atheroprotective effects within advanced atherosclerotic lesions at least in part through inducing favorable changes in SMC phenotype. Studies will test how SMC-specific or global genetic or pharmacologic inhibition (Aims 2a-2c) or augmentation (infusion of rPDGF- DD, Aim 2d) of PDGFβR signaling in Western diet fed ApoE-/- mice with advanced atherosclerotic lesions impacts overall lesion pathogenesis, indices of plaque stability, SMC phenotypic transitions, and the incidence of plaque rupture. Results may lead to development of novel therapeutic approaches for reducing late stage clinical complications of atherosclerosis by inducing SMC to undergo beneficial changes in phenotype-function that promote formation of a thicker and mechanically more stable fibrous cap, thus reducing the probability of plaque rupture and a possible MI or stroke.

Public health relevance
Project Narrative/Relevance: Atherosclerosis is a progressive disease that is a leading cause of death in the world. Remarkably, despite decades of research, little is known about late stage lesion development and mechanisms that result in the rupture of advanced atherosclerotic lesions leading to catastrophic thrombotic events including a heart attack (i.e. myocardial infarction) or a stroke. Drugs for reducing the probability of plaque rupture have largely focused on lipid lowering compounds and anti-inflammatory agents which thus far have only modestly reduced event rates or had no effect. The long term goal of studies in this proposal is to develop a completely novel approach for reducing the late stage clinical complications of atherosclerosis by inducing vascular smooth muscle cells (SMC) to undergo favorable changes in phenotype-function that promote formation of a thick mechanically stable fibrous cap (i.e. analogous to a patch on a tire) on advanced atherosclerotic lesions, thereby reducing the probability of them rupturing and setting off a possible heart attack or stroke.